Mechanisms of human adipose depot development and impact of Diabetes

ABSTRACT
More than total adiposity, the relative distribution of adipose tissue among central and peripheral depots is
a critical determinant of Type 2 Diabetes (T2DM) and cardio metabolic disease risk. The goal of this
proposal is to use novel mesenchymal progenitor cell derivation and single-cell clone genomic sequencing
approaches to fully identify and characterize the diversity of adipocytes that compose these human depots and
their developmental mechanisms. To this end, we will leverage exciting recent methods whereby we can
generate large numbers of mesenchymal progenitor cells from human adipose tissue with minimal loss of
multipotency. These cells differentiate into adipocytes that are similar to those from the depot of origin, and
their transcriptomes reveal the existence of at least three types of “white” human adipocytes, as well as the
thermogenic “beige/brite” type. We are now in a strong position to test the hypothesis that metabolically
distinct human adipose depots, gluteal and abdominal, are composed of different adipocyte classes that
develop from specific mesenchymal progenitor cells, and to provide full transcriptomic profiles of these
adipocytes and their progenitors. Furthermore, it is known that diabetes affects multipotent progenitor cells,
leading to impaired capacity to generate healthy adipocytes and repair tissue, further deterioration of insulin
responsiveness. We will test the hypothesis that human T2DM alters mesenchymal progenitor diversity
and determine how this defect leads to abnormal adipose tissue development in vivo. Our specific aims are:
1. To test the hypothesis that the different functional properties of human adipose tissue depots are due to
intrinsic differences in their content of adipocyte subtypes derived from specific mesenchymal progenitor
cells. 2: To test the hypothesis that T2DM preferentially impairs development of specific mesenchymal
progenitor subsets and adipocytes derived from these cells, and 3: To define the physiological properties of
adipocyte subtypes through tissue generation in vivo. These studies will provide a new high-resolution view
of the cellular structure of human adipose tissue depots, of developmental mechanisms that lead to adipocyte
subtypes, and insight into developmental alterations that contribute to T2DM physiopathology.

Public health relevance
NARRATIVE While there’s a strong relationship between weight gain and the onset of diseases such as Type 2 Diabetes and heart disease, the most important factor seems to be where within the body excess fat is carried. Individuals who accumulate fat around their belly are much more at risk of developing diabetes and heart disease than those who accumulate fat in their lower body. There is strong indication that genes contribute to these differences, but how these genes work is not clear. Our research uses small amounts of human fat from different depots to study cells called mesenchymal progenitors, which are the ones that become fat cells. We believe that understanding the differences in genes expressed in mesenchymal progenitors from belly fat or lower body fat, and how they become different types of fat cells will help us understand how different fat depot form, and why they are different between people. It will also help us understand why lower body fat is beneficial, and maybe recapitulate these beneficial effects in ways that can improve health.